Engineering Cell-Substrate Interactions on Porous Membranes to Create Physiologically Relevant Model Systems

Abstract
A significant shift is underway in many fields of biomedical research that are rapidly adopting
microphysiological systems, also known as tissue chips. Microphysiological systems are being
used by biomedical scientists for drug and toxicity testing, disease modeling, and to answer
fundamental questions about cell-cell interactions in complex, but tightly controlled
environments that can be parallelized for high throughput studies, often with high-resolution
microscopy and other real-time readouts. In some studies, induced pluripotent stem cells
(iPSCs) allow patient-specific models of drug testing, offering physiological relevance that
cannot be matched by any animal model.
A central component of nearly all microphysiological systems is the semi-permeable synthetic
membrane that facilities co-culture or establishment of a tissue barrier model. This membrane
serves to compartmentalize cells or microenvironments while also selectively allowing some
species and even cells to transit or transmigrate, typically based simply on a pore size cut-off.
While pore size is important for controlling communication between compartments or opposing
sides of a barrier model, the membrane also serves as a support scaffold and culture substrate
of nearly all cells involved in the system. The overall vision of this MIRA research program is to
answer key questions in two interrelated domains: Improve the Understanding of Biological
Mechanisms of Cell-Substrate Interactions on Porous Materials, and Advance Ultrathin
Membrane Development and Engineer the Ideal Membrane for Physiologically Relevant Tissue
Barrier and Co-Culture Models. For the next five years, this research program is focused on
building upon my laboratory’s expertise in cell-substrate interactions and materials engineering,
and evolving from biophysically focused analysis to understanding the molecular and signaling
pathways that are likely driving cellular behaviors with the goal of engineering advanced
membranes for more physiologically relevant tissue barrier models. Additionally, my laboratory
seeks to move toward an understanding of the dynamics and equilibrium of cell-substrate
interactions, particularly in the context of the transition between healthy and disease states in
these microphysiological systems.

Public health relevance
Narrative The overall goal of this research proposal is to understand how cells behave on porous substrates and then engineer ideal membranes to integrate into in vitro tissue barrier and co- culture models. These models will aid in drug candidate screening as well as improve our understanding of how cells communicate under normal and pathological conditions in the body.